Medical Scientist Training Program (T32 NRSA Training Grant)

PROJECT SUMMARY
This application requests resources to support the goal of training the next generation of physician-investigators
by offering a rigorous, integrated, and supportive educational experience leading to both M.D. and Ph.D. degrees
at UCSF. Our MSTP offers the combination of an outstanding public medical school with an innovative
curriculum, committed and renowned faculty, and a collection of premier graduate training programs. The guiding
principles have been: (1) selecting outstanding students who are committed to careers as physician-investigators
and who have the academic ability and interpersonal skills to excel in medicine and science; (2) offering the best
possible training leading to combined M.D. and Ph.D. degrees without compromising the quality of training for
either degree; and, (3) actively engaging the UCSF School of Medicine (SOM) and Graduate Programs to
optimize the training path of each student and to encourage efficient completion of both degrees. The UCSF
MSTP attracts and trains exceptional students who have a remarkable record of success. The leaders of the
SOM have demonstrated an extraordinary level of commitment to the program, which with 96 trainees now
enrolled, has reached steady enrollment. New activities to enhance and optimize the training of students have
been added during the current period of support. Our trainees have formed a strong community that has engaged
the faculty to enhance the training environment at UCSF. The achievements of our students and their subsequent
track records underscore the value of this combined degree program.
This application is directly relevant to the mission of the NIGMS and NIH as it requests funds to support mentored
career development for the next generation of physician-scientists. This MSTP represents an investment in the
future of our nation’s health as the researchers who are trained through this award will be optimally prepared to
harness discovery-based research strategies to attack urgent problems in human health with the goal of
developing and implement innovative new treatments.

Public health relevance
PROJECT NARRATIVE: Attacking complex diseases such as cancer, arthritis, and Alzheimer’s dementia will require a new generation of researchers who are both outstanding physicians and skilled scientists who understand how to harness new technologies to advance human health. This application requests support for the Medical Scientist Training Program at the University of California, San Francisco, which is achieving this goal by offering a rigorous, integrated, and supportive program that results in graduates who hold both M.D. and Ph.D. degrees.